Collaboration and Service

Project Summary The overall goal of the collaboration efforts of the Yeast Resource Center is to continue refining technologies developed within the center while simultaneously providing access to expertise and resources to the scientific community. Our resource has been an invaluable collaborative resource for the scientific community by making available advanced technologies developed by the center. In the last 5 years our Biomedical Technology Research Resource (BTRR) has had a total of 347 collaborations that are widely distributed throughout the United States. Collaborations differ from our Driving Biomedical Projects in that they don't require the development of new technologies but instead directly apply more established methods that make use of the expertise, instrumentation, software, and protocols facilitated by our resource. We have a history of openly supporting the scientific community by accepting collaborations that align with our expertise. A strength of a “Yeast” resource center is that we have been a valuable resource and source of collaboration for the yeast scientific community. These collaborations have become an excellent opportunity in refining our established technologies. Once refined, methods often get extended to collaborations in experimental systems beyond yeast as the technology matures.